Consortium for Autism, Neurodevelopmental Disorders, andDigestive Diseases (CANDID)

ABSTRACT There is an increased prevalence of gastrointestinal disorders (GI) in patients with neurodevelopmental disorders (NDDs) and autism. A diverse set of GI conditions with very high prevalence in the autism community are defined as functional gastrointestinal disorders (FGIDs) by international consensus via the Rome IV Criteria, the symptoms of which likely have a neurological basis (2). GI symptoms are one of the main determinants for decreased quality of life in patients and may include: GERD, IBS-­?like symptoms, dysmotility, chewing and swallowing dysfunction, feeding difficulty, gastroesophageal reflux, delayed gastric emptying, biliary tract disease, gas bloating, and constipation (1). The prevalence of FGIDs in these populations may be a gross under-­?estimate because many of these patients are nonverbal and do not express pain and discomfort normally (1). Failure to thrive can develop due to feeding problems and growth problems persist into adulthood in some disorders. A percentage of individuals with NDDs have G-­?tubes and GJ-­?tubes placed to facilitate feeding. Patients are often hospitalized due to the severity of symptoms and GI symptom-­?induced stress contributes to increased seizure frequency and sleep disturbance. The proposed meeting “Consortium for Autism, Neurodevelopmental Disorders, and Digestive Diseases (CANDID)” aims to convene stakeholders from NIH Institutes, patient advocacy groups (Rett Syndrome Research Trust, RettSyndrome.org, Dravet Syndrome Foundation, Phelan-­?McDermid Syndrome Foundation, PTEN Hamartoma Tumor Syndrome Foundation, ADNP Kids Research Foundation, Dup15Q Alliance, Angelman Syndrome Foundation, SYNGAP Education and Research Foundation, Ring14 USA, International Foundation for CDKL5 Research, Autism Science Foundation, and Autism Speaks), and academia in a coordinated effort to develop a set of short-­? and long-­?term goals for both basic and clinical research in digestive health across autism spectrum disorders and other NDDs to increase therapeutic discovery for GI disorders in traditionally under-­?funded neurological rare diseases. Patient advocacy leaders will provide necessary and complementary insights to that of clinical and research experts to write competitive applications to relevant NIH ICs, with the potential for the creation of content-­?specific interdisciplinary research teams. During the meeting, we will form working groups composed of relevant experts in these fields, so that at the conclusion of the conference, momentum for these goals can continue. Specifically, we aim to (1) begin the development of a catalog of existing clinical and genetic data repositories maintained by individual organizations with relevance to exploratory research into digestive diseases in the autism and NDD community, (2) publish a summary of the discussion and consensus in the scientific literature, and develop a web page as a resource for shared repositories and facilitation of collaboration, and (3) inform postgraduate medical education for pediatric and adult GI fellows focused on the needs of patients with ASD.

Public health relevance
NARRATIVE The burden of frequent gastrointestinal complaints in individuals with neurodevelopmental disorders (NDDs) and on their families is tremendous. Constipation alone can account for thousands of dollars of additional healthcare costs to families, but also a great deal of missed work and school. In order to move science and medical understanding forward for these problems, we are proposing a meeting called the “Consortium for Autism, Neurodevelopmental Disorders, and Digestive Diseases (CANDID)”. This represents a unique opportunity to gather stakeholders from academia, the relevant offices of NIH, and patient advocacy groups (PAGs) to address GI disorders in autism and NDDs and encourage collaboration among attendees and facilitate innovation. This conference also proposes to develop working groups that can address specific elements of research so that progress can continue beyond the conference, including ways to measure quality of life in NDDs and gastrointestinal problems, ways to improve medical education for these problems, and ways to ensure that researchers from different areas can continue to collaborate by building clinical data repositories.